Renal Circulatory Adaptation in Healthy and Complicated Pregnancies

PROJECT SUMMARY/ABSTRACT
Aligning with the NIH-NIDDK goal of “advancing our understanding of the pathophysiology of sex differences in
CKD and improving clinical care of women with CKD” outlined at the 2017 “Sex and the Kidney: Sex
Differences in Renal Disease” workshop, this proposal focuses on defining renal adaptation to pregnancy and
strategies to identify women with CKD at high risk for pregnancy complications. Growing evidence suggests a
strong link between kidney function and preeclampsia, yet significant gaps persist in our knowledge of renal
adaptation in pregnancy. Aim 1A of this proposal utilizes existing data and blood samples from two large
prospective longitudinal pregnancy cohorts to study pregnancy-associated changes in glomerular filtration
markers in healthy and complicated pregnancies. Preliminary data suggests impaired glomerular hyperfiltration
is associated with placental dysfunction, and in Aim 1B we will investigate metabolite and angiogenic
pathways critical for placental development in women who fail to mount normal pregnancy-associated
hyperfiltration. Studying over 3,000 pregnant subjects, this work will define gestational renal physiology in a
diverse obstetric population and identify pathways linking kidney function and fetoplacental development that
may be targeted to reduce preeclampsia in women with kidney disease. In Aim 2, we will measure and study
pre-conception renal functional reserve as a predictor of pregnancy-associated glomerular filtration and
preeclampsia in women with kidney disease. Together, understanding the effects of renal adaptation and
glomerular hyperfiltration before and during pregnancy will yield new metrics by which to evaluate and treat
young women with kidney disease planning pregnancy. Dr. Tangren completed her medical degree at the
University of Pennsylvania and her internal medicine and nephrology training at Brigham and Women’s
Hospital and Massachusetts General Hospital. She recently completed a Master’s in Public Health at the
Harvard T.H. Chan School of Public Health and holds a faculty appointment in the Massachusetts General
Hospital Nephrology Division and Harvard Medical School. During this career development award, she will
devote 75% of her time to focus on this research plan and complete didactic and hands-on training in
physiologic investigation and metabolic pathway analysis through coursework and applied analytic experience.
Dr. Tangren will benefit from the guidance of her primary mentor, Dr. Sushrut Waikar, an international leader in
CKD epidemiology and biomarkers studies, and her co-mentor Dr. Ravi Thadhani, a clinical and translational
preeclampsia investigator. Her training will be overseen by an advisory committee of senior scientists, Drs.
Ellen Seely, Lesley Inker, and Jeffrey Ecker, with collective expertise in metabolism in pregnancy, glomerular
filtration measurements and obstetrics research. She will work in collaboration with Dr. Eugene Rhee (kidney
disease metabolomics) and Dr. Sophia Zhao (biostatistics). Dr. Tangren’s goal is to become an independent
clinician-investigator with a research program focused on reproductive health in nephrology.

Public health relevance
PROJECT NARRATIVE Preeclampsia is a leading cause of maternal morbidity and mortality and disproportionately affects women with chronic kidney disease (CKD), which afflicts 3-5% of women in their reproductive years in the United States. Despite overwhelming evidence on the link between kidney disease and preeclampsia, we have little understanding of normal and abnormal renal physiology in pregnancy. The current proposal is to study renal adaptation in pregnancy by performing novel assessments of kidney function, including the assessment of renal functional reserve and analysis of novel glomerular filtration markers, before and during pregnancy; knowledge gained from this proposal will help define the relationship between kidney function and fetoplacental development, ultimately leading to improved care for women with CKD and their offspring.